Reducing Suicide-Specific Rumination in Veterans using Real-time Functional Magnetic Resonance Imaging Neurofeedback

Project Summary
Suicide is much higher in Veterans compared to non-Veterans and thus remains a major health crisis in the
VA, but there are few treatments available that directly target core features of suicidal thoughts and behaviors.
Rumination is the strong tendency to engage in self-critical repetitive thinking that is often difficult to interrupt
and is associated with suicide attempts and the transition from suicidal ideation to intent above and beyond
other suicide risk factors. Meta-analyses indicate that abnormalities in brain regions comprising the “default
mode network,” which play a role in daydreaming or mind-wandering, contribute to the maintenance of
rumination. More specifically, deficits in the medial orbital frontal cortex, which plays a crucial role in inhibition,
could allow seemingly innocuous stimuli to become integrated with autobiographical features of the self via the
precuneus and the over personalization of negative stimuli leading to rumination, thus highlighting a neural
circuit through which rumination may be perpetuated and a potential target for intervention. Functional
magnetic resonance imaging studies have provided key insights into the neurobiology of suicide, but has had
little direct impact on clinical care thus far. With the advent of real-time functional magnetic resonance imaging
neurofeedback, however, there is now the potential to implement personalized strategies for altering brain
activity associated with rumination to reduce suicidal thoughts and behaviors. In the proposed study we will
determine the acceptability and feasibility of using real-time functional magnetic resonance imaging
neurofeedback to reduce suicide-specific rumination, defined as “repetitive mental fixation on one's suicidal
thoughts and intentions” in a transdiagnostic sample of 15 Veterans at elevated risk of suicide. We will also
assess pre- to post-treatment changes in measures of suicide-specific rumination, disability, functional
impairment, and quality of life in Veterans with a suicide attempt history following 2 real-time functional
magnetic resonance imaging sessions (each one lasting ~50 minutes). Veterans will be provided signals from
the brain to identify mental strategies (e.g., cognitive reappraisal) for reducing the connectivity influence of the
medial orbital frontal cortex on the precuneus. During a subsequent “transfer” period Veterans will be asked to
utilize the mental strategy that worked best for altering this connectivity, but without receiving any
neurofeedback signals from the brain. Post-treatment clinical assessments will occur following each of the 2 rt-
fMRI neurofeedback sessions and at 1 month following the second fMRI neurofeedback session. The novelty
of the proposed work is underscored by the paucity of work using real-time functional magnetic resonance
imaging neurofeedback in a Veteran population and the lack of studies to date targeting a brain network to
reduce suicide-specific rumination. In this SPiRE application we will test the following specific aims: (1) to
determine the acceptability and feasibility of implementing real-time functional magnetic resonance imaging
neurofeedback in a Veteran population experiencing suicide-specific rumination; (2) to identify changes in
suicide-specific rumination following rt-fMRI neurofeedback and (3) to identify changes in functional impairment
and quality of life following rt-fMRI neurofeedback. The proposed study is consistent with the mission of RR&D
to maximize Veterans’ functional independence, quality of life and participation in their lives and community
and the SPiRE mechanism to fund studies for “feasibility of an intervention.” These data will guide a future VA
Merit Award application using a randomized double-blind, placebo-controlled study to test the efficacy of rt-
fMRI neurofeedback as a first-line treatment intervention for reducing suicide-specific rumination in Veterans.

Public health relevance
Project Narrative Few treatments target core features of suicidal thoughts and behaviors in Veterans. In the proposed SPiRE study we will determine the acceptability and feasibility of using real-time functional magnetic resonance imaging neurofeedback for reducing suicide-specific rumination, defined as a “repetitive mental fixation on one's suicidal thoughts and intentions” in a transdiagnostic sample of Veterans at elevated risk of suicide. Veterans will learn strategies for modulating activity within brain regions comprising the default mode network, which has been demonstrated to contribute to the maintenance of rumination, as they receive feedback signals from the brain. These data will be used to guide a future randomized double-blind, placebo-controlled study to test the efficacy of real-time functional magnetic resonance imaging neurofeedback as a first-line treatment intervention for reducing suicide-specific rumination in Veterans.